Borrelia burgdorferi responses to antibiotic stresses

ABSTRACT Lyme disease, which is caused by the spirochete Borrelia burgdorferi, is generally treatable by a 2-4 week course of antibiotics. However, there is strong evidence from studies of human patients and experimental animals that antibiotics do not always clear B. burgdorferi infections. Studies of other bacterial species have revealed genetically-encoded physiological adaptations to antibiotic stresses, such as altering expression levels of target proteins or metabolic enzymes. To gain insight on whether the Lyme spirochete also adapts to antibiotic stresses, we will examine the transcriptomes and proteomes of B. burgdorferi that are exposed to sub-lethal and lethal concentrations of antibiotics that are commonly used to treat human Lyme disease infections. Results of these studies will reveal whether B. burgdorferi possesses genetically-encoded adaptive mechanisms, which can then be targeted for development of improved therapeutics.

Public health relevance
PROJECT NARRATIVE Evidence exists that the spirochete bacterium Borrelia burgdorferi, the agent of Lyme disease, may possess mechanisms to avoid killing by antibiotics during human infection. Some other pathogenic bacteria undergo genetically-encoded physiological adaptations to antibiotic stresses, such as altering expression levels of target proteins or metabolic enzymes. We hypothesize that the Lyme disease spirochete also adapts to antibiotic stresses, which we will address by comparing the transcriptomes and proteomes of B. burgdorferi that are exposed to antibiotics which are commonly used to treat human Lyme disease.